University of Michigan BACPAC Mechanistic Research Center

Project Summary / Abstract Chronic Overlapping Pain Conditions (COPCs) represent up to 50% of all chronic pain cases, occur more commonly in women, and can be more debilitating than other forms of chronic pain. These conditions include but are not limited to the following: temporomandibular disorders (TMD), fibromyalgia (FM), irritable bowel syndrome (IBS), vulvodynia (VVD), interstitial cystitis/painful bladder syndrome (IC/PBS), painful endometriosis (ENDO), chronic tension type headache (cTTH), migraine headache (MI), chronic low back pain (cLBP), and myalgic encephalomyelitis/chronic fatigue syndrome (ME/CFS). Common neurobiological substrates (e.g., central sensitization) have been suspected to account for the overlap; but until recently, it has been difficult to efficiently classify each of these conditions within individuals. A digital, logic driven classification tool has been developed for this purpose but access to the tool remains limited. Here we propose converting this COPC classification tool into the REDCap format so that it will be more broadly accessible by academic researchers including those involved in the HEAL initiative. Following the REDCap conversion of the COPC screener, a small validation study will help to assure that the new format retains its construct validity, usability, and equivalence to existing versions of the instrument.

Public health relevance
Project Narrative Chronic Overlapping Pain Conditions (COPCs) represent up to 50% of all chronic pain cases, yet the ability to study the neurobiological mechanisms underlying these conditions has been hampered by the lack of a standardized and efficient method of classifying each of these conditions within individuals. Recently a new measure was developed for this purpose but needs to be converted and validated for the REDCap platform. Conversion into REDCap will make this classification tool more broadly available to academic researchers and investigators within the HEAL initiative.